Administrative Core

PROJECT SUMMARY ABSTRACT
The administrative core of this program is integrated into the Gene and Cell Therapy Program within the Wells
Center for Pediatric Research at Indiana University. It provides the mechanism for pre- and post-award
administration of the program, for regular and effective interactions of the investigators who constitute the key
personnel of the projects and cores, and for assembling the Internal and External Advisory Committee to provide
ongoing peer review and input to all programmatic initiatives. The administrative core interacts at all levels with
the central administration of Indiana University School of Medicine and the Wells Center for Pediatric Research.
The Administrative core will foster reproducibility and rigor in scientific progress through provision of statistical
support, organization of data collection and access, exchange and coordination of scientific progress, and
inclusion of trainees and mentees in web conferences, meetings, and symposia. The Core will provide budgetary
oversight over the program and also coordinate and maintain documentation of institutional regulatory approvals,
arrange for the resolution of potential conflicts, facilitate electronic file sharing for administrative and scientific
purposes and for preparation of publications, as well as sharing of reagents, protocols, and experimental models
within the program and with others in the scientific community. Further the Core will facilitate integration of
trainees and mentees and help enrich their training experience through inclusion in scientific activities and
discussions, a seminar series, and an annual symposium.